Stroke and Cardiovascular Research Training (SCaRT) Institute

PROJECT SUMMARY
The WHO estimates that NCDs are the 2nd leading cause of death in sub-Saharan Africa (SSA), accounting for
30% of the 9.5 million deaths in Africa. The number of people with hypertension in SSA will increase by 68%
from 75 million in 2008 to 126 million in 2025. In Ghana and Nigeria, the burden of stroke and CVD has grown
in the past decade; and it is estimated that the scant resources in SSA countries would be depleted by the
disability from CVD if this epidemic go unabated. Thus, strengthening research capacity in prevention of stroke
and CVD is an urgent priority. However, research productivity and collaboration among African scientists is
abysmally low. In order to address this problem, we developed a Cardiovascular Research Training (CaRT)
program (D43TW009140; MPI: Ogedegbe, Adanu & Tayo) that trained 64 investigators between 2012-2017
in Ghana and Nigeria. Led by 4 accomplished African scholars (Ogedegbe, Adanu, Ovbiagele & Tayo),
this renewal application, will broaden the scope of CaRT to include stroke prevention. The proposed
program, known as Stroke-CaRT, is a consortium of NYU, UCSF, Loyola University and two African countries
(Ghana and Nigeria). We will enroll 100 trainees in 4 cohorts of 25 trainees (12-13 from each country) in
either a Health Services Research (HSR) track or a Patient-Oriented Research (POR) track. Trainees in the
HSR track will be chosen from candidates with a background in public health (nurses, pharmacists, etc.), while
those in the POR track will be chosen from a pool of physicians enrolled in postgraduate residency programs.
The unifying theme of both tracks is trainees’ common interest in stroke and CVD. The 2-year program
comprises: (a) three 2-week Intensive Research Courses in Year 1; and (b) a Mentored Research
Experience in Year 2, during which trainees will conduct Mentored Research Projects and attend monthly
Advance Seminars via WebEx to discuss their progress. We will utilize a multidisciplinary ‘twinning’
strategy whereby trainees with similar expertise will be paired to work in teams of 4 [two from each country] in
order to foster between-country collaborations. The program is built on an infrastructure of NIH grants
between the PIs and their colleagues in Ghana and Nigeria: Bioethics training grant (R25TW010886; Art &
Ogedegbe); implementation research in HTN (U01HL138638; Ogedegbe) and stroke (R21 NS103752;
Ovbiagele), stroke epidemiology (R01NS107900; R21TW010479 & U54HG007479; Ovbiagele); stroke
genomics (R01NS107900; Ovbiagele) and primary stroke prevention in sickle cell disease (R01NS094041;
Debaun M). The training will occur yearly in Ghana and Nigeria, rather than the United States, in order to
mitigate the risk of “brain drain” that is often inherent in sending African scholars abroad for training. Upon
completion, trainees will acquire skills needed to conduct scientifically rigorous research in stroke prevention
and CVD risk reduction in Africa. Our long-term goal is to develop a sustainable network of trainees with
expertise in HSR and POR, who are poised to assume leadership roles in academia in SSA.

Public health relevance
PROJECT NARRATIVE S-CART will address a critical deficiency of African scientists committed to a career in stroke prevention and cardiovascular research. Successful completion of S-CART will lead to the establishment of a sustainable CVD research capacity and innovative and contextualized research projects targeted at stroke and CVD prevention.